IGF::OT::IGF Conference Support for four conferences "Novel Approaches and Challenges to Data Harmonization", "Scientific Progress and Epidemiologic Data", "Think Tank", "NCI CoHort Consortium"

conference support services for following meetings: Novel Approaches and Challenges to Data Harmonization; Enhancing Scientific Progress through Sharing of Epidemiologic Data: Challenges, Needs and Opportunities; Think tank on metabolomics and prospective cohorts: how to leverage resources; and NCI Cohort Consortium Annual Meeting